Risk Factors for Microscopic Colitis

PROJECT SUMMARY
Microscopic colitis is the most common cause of chronic watery diarrhea in older adults. The symptoms of this
disease are debilitating. Patients describe isolation and withdrawal from social life and activities. Treatment is
limited to expensive therapies that are sometimes ineffective. Disease relapse is common after medications
are stopped. Although the incidence is comparable to inflammatory bowel disease, the disease has received
much less research attention. A number of medications (PPIs, NSAIDs, statins, SSRIs) have been linked with
microscopic colitis. Although guidelines suggest discontinuing these medications as the initial step in
treatment, the evidence supporting this recommendation is weak. The first phase of this study enrolled patients
with microscopic colitis and diarrhea controls. Contrary to existing beliefs, there was no association with
medications previously linked to microscopic colitis. There was a strong inverse association with obesity and
exogenous hormones. Amplicon sequencing by 16S rRNA demonstrated that microbiome alpha-diversity was
significantly lower in microscopic colitis cases compared to controls. Several taxa were enriched in cases. The
present study is designed to extend and expand on the initial findings. The aims of the proposed case-control
study are: 1) To investigate medications, oral contraceptives, postmenopausal hormones and obesity by
comparing microscopic colitis cases to two comparison groups – patients referred for colonoscopy for diarrhea
and colonoscopy for colorectal cancer screening. 2) To use shotgun metagenomic sequencing to gain insight
into biodiversity and function. 3) To use RNA sequencing of mucosal samples from microscopic colitis patients,
diarrhea controls and screening controls to reveal genetic signatures associated with microscopic colitis and
discover potential druggable disease targets. The study will enroll 150 microscopic colitis cases, 300 diarrhea
controls and 300 screening colonoscopy controls. Biopsies from the colon will be used to evaluate adherent
bacterial organisms and to conduct RNAseq experiments in 100 microscopic colitis cases, 100 diarrhea
controls and 100 screening colonoscopy controls. Structured telephone interviews will obtain detailed dietary,
medication and lifestyle information on study subjects. The prospective data collection corrects important
limitations of prior research by others. The addition of a second control group could provide more definitive
evidence to avoid unnecessarily stopping therapeutically important medications (PPIs, NSAIDs, statins,
SSRIs). Shotgun metagenomics could provide information on microbial etiology or functional genes potentially
leading to strategies to prevent or treat the disease. The study will improve our understanding of risk factors,
set the stage for more scientifically grounded future research, and potentially suggest new interventions for a
disease that is currently poorly understood.

Public health relevance
PROJECT NARRATIVE Microscopic colitis is a common cause of watery diarrhea particularly in older adults. This often-debilitating disease has received insufficient research attention. The proposed research is designed to improve our understanding of the etiology of microscopic colitis, an important step in developing interventions to decrease the burden.